Reprogramming the tumormicroenvironment to improve immunotherapy of glioblastoma

Glioblastoma (GBM) is a uniformly fatal malignancy with limited treatment options. Immune checkpoint
blockers (ICBs) have revolutionized the treatment of several malignancies, but have failed in all Phase III
trials in newly diagnosed and recurrent glioblastoma (GBM) patients. This limited efficacy of ICBs is due to
profound immunosuppression in the GBM tumor microenvironment (TME) caused by paucity of cytotoxic T
cells, abundance of regulatory T cells, resident macrophages and microglia and infiltration of myeloid-
derived cells from the bone marrow. Wnt signaling fuels GBM progression by aiding proliferation, stemness,
epithelial-to-mesenchymal transition and chemoresistance. However, the role of Wnt signaling in immune
suppression in GBM is not known. In our preliminary studies we found that Wnt signaling is elevated in
murine and human GBMs. A porcupine inhibitor WNT974 -- that blocks Wnt signaling -- in combination with
anti-PD-1 antibody (αPD1) prolonged the survival of GBM-bearing mice. This increased survival was
accompanied by an expansion of a novel DC3-like dendritic cell state and decrease in granulocytic myeloid-
derived suppressor cells (gMDSCs) that may mediate the response to this combination in responding tumors.
By contrast, poorly-responding tumors showed an increase in monocytic (m) MDSCs, insufficient T cell infiltration
and T cell effector function, suggesting potential resistance mechanisms. Our prior work shows that genetic
deletion or pharmacological inhibition of Wnt signaling disrupts the GBM vasculature and makes it leaky.
Moreover, ICBs themselves increase edema in GBM patients and require the use of steroids that are highly
immunosuppressive. Our preliminary studies show that losartan, an angiotensin receptor blocker, can reduce
αPD1-induced edema and reprogram the immunosuppressive TME to an immunostimulatory milieu to favor T
cell infiltration and effector function. Building on these exciting findings, our overarching hypothesis is that Wnt
signaling reprograms the GBM tumor microenvironment from immune suppressive to immune
stimulatory, thus potentiating αPD1 therapy, and adding losartan further enhances the outcome by
overcoming treatment resistance mechanisms, and reducing edema. We will test this hypothesis by
examining the function of (a) antigen cross-presenting DCs and (b) decreased gMDSCs in mediating the
response to WNT974 and αPD1 (Aim 1). We will also test the hypothesis that resistance to WNT974+αPD1
is caused by (a) increased mMDSCs and (b) lack of T cell infiltration and function (Aim 2). In Aim 3, we will
test the hypothesis that the combination of losartan with Wnt-inhibition and αPD1 will (a) reduce mMDSCs
infiltration and increase T cell infiltration and effector function and (b) alleviate edema and provide durable
responses in GBMs that are refractory to WNT974+αPD1. If successful, our results will inform the design of
future GBM clinical trials to improve the outcome of ICBs using agents currently in clinical trials for non-CNS
tumors (WNT974: e.g., NCT01351103; and losartan: NCT03563248).

Public health relevance
PROJECT NARRATIVE The immune suppressive tumor microenvironment in glioblastoma (GBM) contributes to the failure of immune checkpoint blockers (ICBs). By reprogramming the GBM microenvironment using Wnt-inhibitor and losartan, our project will i) provide unprecedented insights into the mechanisms of response and resistance to combined Wnt signaling inhibition and αPD1, and ii) utilize losartan, a safe, inexpensive and widely prescribed angiotensin receptor blocker, to alleviate edema and resistance to this combination and thereby improve outcome of ICBs in GBM. If successful, our results will inform the design – and catalyze the initiation – of clinical trials in GBM patients to improve the outcome of ICBs using agents currently in clinical trials for non-CNS tumors (WNT974: e.g., NCT01351103; and losartan: NCT03563248).